Endocannabinoid Discrimination

DESCRIPTION (provided by applicant): The endocannabinoid (eCB) system is one of several lipid signaling systems in the brain and in the body. Verified components of this system include two G-protein coupled receptors, their signaling pathways, two predominant endogenous ligands [anandamide (AEA) and 2-arachidonyl glycerol (2-AG)], and their synthetic and metabolic pathways. The system plays an important modulatory role in many crucial CNS processes (e.g., brain reward, appetite regulation, cognition). Consequently, it is not surprising that this system has been implicated in the pathophysiology of a variety of health problems related to these processes, including substance abuse, eating disorders, other types of addictive behavior, and psychiatric disorders. Although research in cells or tissues suggest that there are differences between AEA and 2-AG, examination of potential behavioral consequences of these differences is sparse. Yet, the health problems, for which dysregulation of eCBs in the CNS is most strongly implicated, are problems in which behavior is central. Hence, one of the first steps towards delineation of physiological role(s) that AEA and/or 2-AG may play in health problems such as substance abuse is to distinguish similarities and differences in effects of these two eCBs in pharmacologically selective and validated behavioral procedures relevant to cannabinoid abuse. To this end, two mouse models, drug discrimination and intracranial self-stimulation (ICSS), will be used (Aims 1 and 2). Drug discrimination is an animal model of the subjective effects of psychoactive drugs in humans whereas ICSS represents a method used to evaluate the effects of drugs and behavioral or genetic manipulations on brain reward processes. Each of these factors is known to play a strong role in substance abuse. In addition, brain reward processes undoubtedly are involved in other forms of addictive behavior such as binge eating. The primary guiding idea underlying the proposed studies is that finer distinctions among functions of individual eCBs will be facilitated by knowing the extent to which their behavioral endpoints differ. Further, selected pharmacodynamic mechanisms that may be responsible for differences in the behavioral profiles of these eCBs will be examined (Aim 3). Namely, the relative efficacies and potencies of AEA and 2-AG at a level signal transduction that is a proximal to the ligand-receptor interaction (G-protein activation) will be determined, as the nature of this interaction is associated with alterations in behavioral responses. Results of the proposed studies will enhance understanding of how the eCB system (and especially each of the two major eCBs, AEA and 2-AG) is involved in physiological and pathophysiological processes related to substance abuse. This knowledge, combined with the current rapid development of pharmacological tools to manipulate this system (e.g., inhibitors of eCB synthesis and metabolism), also has the potential to lead to more effective therapeutic agents for health problems related to dysregulation of the eCB system.

Public health relevance
PUBLIC HEALTH RELEVANCE: Anandamide (AEA) and 2-arachidonyl glycerol (2-AG), the two primary endocannabinoids, play an important modulatory role in many crucial CNS processes such as brain reward, appetite regulation, and cognition. Previous research suggests that dysregulation of the endocannabinoid system is one of the mechanisms involved in substance abuse. Distinguishing the individual roles of AEA and 2-AG in processes related to substance abuse (i.e., subjective effects and brain reward), as is proposed in this project, has the potential to increase understanding of the physiological role(s) of the endocannabinoid system and to serve as a basis for rational choice of pharmacological tools to manipulate this system for therapeutic purposes. Anandamide (AEA) and 2-arachidonyl glycerol (2-AG), the two primary endocannabinoids, play an important modulatory role in many crucial CNS processes such as brain reward, appetite regulation, and cognition. Previous research suggests that dysregulation of the endocannabinoid system is one of the mechanisms involved in substance abuse. Distinguishing the individual roles of AEA and 2-AG in processes related to substance abuse (i.e., subjective effects and brain reward), as is proposed in this project, has the potential to increase understanding of the physiological role(s) of the endocannabinoid system and to serve as a basis for rational choice of pharmacological tools to manipulate this system for therapeutic purposes. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS One of the unresolved issues concerning endocannabinoids (eCBs) is distinction between the effects of the two major eCBs, anandamide (AEA) and 2-arachidonyl glycerol (2-AG). This distinction is important not only for determination of the potential physiological roles of these eCBs, but also for guiding research into the therapeutic uses of their manipulation, including novel treatments for substance abuse. We are particularly interested in determination of any differences between the effects of these two eCBs with respect to modulation of behaviors related to marijuana abuse. To this end, our specific aims will examine eCB effects in drug discrimination (specific aim 1) and intracranial self-stimulation (ICSS) [specific aim 2], animal models of the subjective effects of psychoactive drugs and of brain reward, respectively. In specific aim 3, we will investigate potential mechanisms related to pharmacokinetics and selected pharmacodynamic mechanisms (e.g., localization of efficacy differences between AEA and 2-AG). Specific aim 1. Characterize the discriminative stimulus (DS) effects of AEA and 2-AG. 9- Tetrahydrocannabinol (THC) produces myriad pharmacological effects in rodents. Perhaps the most pharmacologically selective of its cannabinoid effects, however, is its DS effects. Work in this lab and others examining the DS effects of AEA and its analogs has shown partial, but not complete, overlap with THC. To date, research on the behavioral pharmacology of 2-AG has been hampered by the lack of an effective inhibitor of its metabolism (which is now available - see preliminary data section). Aim 1 will characterize the DS effects of the eCBs, AEA and 2-AG. Here, emphasis will be placed on identification of differences in the DS effects of exogenous vs. endogenous cannabinoids as well as on differences among eCBs that may contribute to their pharmacological profiles as compared to THC as well as to each other. Our hypothesis is that, although the DS effects of THC, AEA, and 2-AG overlap to some degree, they are not entirely identical. In order to investigate further the distinctions among the DS effects of these cannabinoid ligands, we will employ a two- factor model of discrimination, in which the training drug serves both as a DS and as a conditioned stimulus (the latter, through its interactions with the reinforcer). By systematic variation of parameters related to these factors (e.g., type of reinforcer, stimulus control assessment), we will determine conditions under which maximal functional differences between AEA and 2-AG are present. This knowledge may, in turn, provide valuable insight into behavioral domains in which AEA and 2-AG may play different roles (e.g., different interoceptive effects that may serve as cues for behavior, differential modulation of stimulus control). Specific aim 2. Determine the effects of eCBs on ICSS. Aim 2 will examine the modulatory effects of eCBs on brain reward systems through use of ICSS. ICSS is a method whereby rodents are trained to press a lever in order to obtain electrical stimulation of a brain area associated with pleasure. An advantage of using this model over other reward models such as self-administration or conditioned place preference is that the modulatory effects of eCBs can be assessed in the absence of administration of a specific drug of abuse. eCB modulation of brain reward systems will be investigated in the ICSS model in mice with eCB systems that have been altered through exogenous administration of eCB or through genetic manipulation. Our hypothesis is that these alterations in eCB system will be associated with changes in responding reinforced by ICSS. Further, the nature of these changes will be dependent upon the component of the eCB system (e.g., receptor, metabolic enzyme) that is altered. Specific aim 3. Investigate the role of pharmacokinetic and pharmacodynamic mechanisms in the DS and reward modulatory effects of AEA and 2-AG. Aim 3 will examine selected mechanisms that may underlie observed differences in the behaviors measured in the other two aims. Given the rapid metabolism of eCBs upon systemic administration and our proposed use of metabolic inhibitors, one of the first steps will be to investigate pharmacokinetic factors that may play a role. In addition, we will determine CB1 receptor functioning (potency and relative efficacy for G-protein activation) for each eCB in selected brain regions with different expression levels of CB1 receptors. Our hypothesis is that pharmacokinetic factors cannot entirely account for pharmacological differences among eCBs and that a brain regional determination of relative efficacy differences for G-protein activation between AEA and 2-AG will reveal region-specific differences in eCB efficacy that correlate with in vivo differences in the DS effects of these drugs and/or their effects on ICSS.